Developing an Ex Vivo Model of the Mesolimbic Pathway for Studying Addiction Phenotypes

Project Summary
Drug abuse and addiction continues to be a major and growing societal problem. It develops during repeated drug use
which causes a series of molecular, transcriptomic, and epigenetic modifications which remodel the neurons in the
mesolimbic pathway leading addictive behavior. Despite extensive studies, treatment options remain limited in part
because the underlying mechanisms contributing to addictive behavior are still not fully understood. Most previous
research to study underlying molecular mechanisms have been performed in animal models specifically mice and rats,
which allow scientists to manipulate a specific variable and assess alterations in drug seeking responses. Despite the
power of these models, there are limitations to how well mice molecular through tissue physiologies correlate to humans.
For example, there are significant differences in the number, cell type compositions, and functions of their respective
mesolimbic pathway neurons. Therefore, there is a need for ex vivo model systems which capture the human genetic,
epigenetic, transcriptional, and multicellular properties of mesolimbic cell types and connections. We will contribute to
this goal by differentiating human stem cells into organoids containing dopaminergic and medium spiny neurons of the
mesolimbic pathway and generate functional synapses between the two. The model will be interrogated by exposing the
cultured neurons to cocaine and studying their molecular, transcriptional, and epigenetic responses and comparing these
responses to available mice and human data. With this model, we can further understand the key underlying mechanisms
that contribute to addiction formation potentially leading to specific targets for drug development.

Public health relevance
Project Narrative The mesolimbic pathway is the main reward pathway in the brain and is linked to addiction among other neurological disorders. The underlying mechanisms leading to addiction formation remain challenging to study, in part due to limitations in animal models to accurately mimic the human cell types and pathways. Here, we propose developing an ex vivo model of the mesolimbic pathway derived from human stem cell cultures which can capture the human genetics, epigenetics, and dynamics molecular response associated with addiction.